Effects of Cannabis Species Labeling and Marketing on Perceptual, Subjective and Objective Use Outcomes

PROJECT SUMMARY
Sale of cannabis for recreational use is rapidly becoming legal across states in the US. While cannabis use
policies typically contain marketing restrictions, including prohibitions on misleading marketing claims, there is
limited research to inform operationalization of these policies, and these policies are rarely enforced. Cannabis
products are often labeled based on “species” or cultivar (Indica, Sativa, or Hybrid). Notably, there is limited
evidence that different species consistently have different profiles of chemical constituents. Despite this,
cannabis is marketed directly to consumers with product labels “Indica”, “Sativa”, and “Hybrid”, and with
corresponding marketing claims that the product has sedative (e.g., relaxation, sleepiness) or energizing (e.g.,
focus, productivity, physical activity) effects. Consumers also report experiencing sedative effects from Indica-
labeled cannabis and energizing effects from Sativa-labeled cannabis. This may translate into unsafe use: our
prior work has found consumers are more likely to report using Sativa-labeled (vs. Indica-labeled) cannabis
before driving or going to work. Despite the potential for public health harm, there is no data demonstrating
whether product perceptions, use expectancies, and subjective and objective acute effects of use vary by label
or marketing claim. Research from other consumer domains, including tobacco, indicates that labeling and
marketing can have powerful effects on product perceptions, use behavior, and use experience. Marketing and
labeling for cannabis could similarly foster inaccurate product perceptions (e.g., regarding harm), expectancy
effects (e.g., anticipating a product to increase focus) and lead to unsafe use (e.g., while driving). This
undermines initiatives to promote safe use of cannabis and risks public health. To date, controlled research
has not systematically evaluated how product labeling (Indica, Sativa, Hybrid) or associated marketing claims
(sedative vs. energizing) affect use behavior, risk perception, or acute drug effects. The proposed research
uses a large-scale content analysis of cannabis labeling and marketing (Aim 1), a randomized online
experiment (Aim 2), and a placebo-controlled randomized laboratory experiment (Aim 3) to document the
scope and effects of cannabis labeling (Indica, Sativa, Hybrid) and marketing claims (sedative, energizing).
Ultimately, this work will provide evidence to inform cannabis marketing and labeling policies, which are
necessary to protect public health.

Public health relevance
PROJECT NARRATIVE Sale of cannabis for recreational use is rapidly becoming legal across states in the US. Products are often marketed directly to consumers using claims that are not supported by evidence. Specifically, products are commonly labeled as “Indica”, “Sativa” and “Hybrid” and are associated with corresponding marketing claims (“Indica” products more likely to have sedative claims, e.g., relaxation, sleep; Sativa-labeled products more likely to have energizing claims, e.g., focus, productivity). The current study provides evidence to inform cannabis labeling and marketing regulations by using a large-scale content analysis of cannabis marketing and labeling, a randomized online experiment, and a placebo-controlled randomized laboratory experiment.